Portfolio Management Systems Support Services (PM3S)

The objective of this requirement is to acquire contract management, program governance, project management, subject matter expertise and consulting, requirements definition, system definition, design, Commercial Off the Shelf (COTS) product customization, and implementation and training support services. The services provided will be in direct support of NCI Scientific and IT portfolios and business operations management including systems, services, contract, project, program, and resource management and governance.